Support via Online Social Networks to Promote safe Infant Care Practices Toward Reducing Racial Disparities in Infant Mortality (SUPERSONIC)

The focus of this renewal application is to build upon the findings from the Influence of Social Networks on
Infant Care and Disparities in Postneonatal Infant Mortality (SONIC) study by conducting a 4-armed
randomized controlled trial (RCT) using online social networks (OSNs) to promote safe infant care practices
and reduce Black/White (B/W) disparities in adherence to these practices. In SONIC, we conducted social
network analysis on 402 new and experienced mothers of young infants. We learned that there are 2 social
network (i.e., family, friends, and peers) types: exclusive (kin-based) and expansive (not kin-based); that
network social norms (group rules defining appropriate behaviors, values, and attitudes) are highly predictive of
infant sleep practices (sleep position, bedsharing, soft bedding use); that mothers are more likely to change
from safe to unsafe practices if their network members espouse unsafe practices; and that Black mothers are
more likely to have exclusive networks, which are more likely to have unsafe practices as the norm. Safe sleep
practices are associated with lower rates of sudden infant death syndrome (SIDS) and unintentional injury-
related deaths (e.g. accidental suffocation) associated with the sleep environment. These sleep-related deaths
(SRDs) remain the leading cause of postneonatal death in the US, with ~3600 deaths/year; Black infants die at
more than double national rates. Thus, differences in social networks and norms contribute to the Black/White
(B/W) disparity seen in safe sleep practices, which in turn contribute to the B/W disparity in postneonatal infant
deaths; the influence of social networks and norms, if contrary to recommended infant care practices, is a
major barrier to acceptance of these practices. OSNs have become a powerful tool for establishing social
norms and influencing behavior, and data suggest that this is equally or more so for Blacks. Thus, our
proposed SUPERSONIC (Support via Online Social Networks to promote Safe Infant Care practices Toward
Reducing Racial Disparities in Infant Mortality) study is the natural next step after SONIC. We plan to test,
through a 4-armed pragmatic RCT, an intervention strategy that uses OSNs (private Facebook groups) to
change social norms among WIC recipient mothers, who have a disproportionate burden of SRDs and high
proportion of Blacks. Mothers in each study arm will participate in an OSN and receive one of 4 messaging
interventions: 1) safe sleep alone, 2) breastfeeding alone, 3) both safe sleep and breastfeeding, and 4) routine
health messages (attention-matched control). Beginning prenatally, we will disseminate via OSNs videos and
messages that address common myths and misconceptions to ultimately impact attitudes and social norms
regarding infant sleep practices and breastfeeding. If utilization of OSNs is effective in changing network norms
and maternal attitudes, and improving adherence, this approach is easily scalable. Moreover, it could be
replicated and potentially readily applied to other health care messages, including vaccine acceptance and
nutrition/obesity.

Public health relevance
PROJECT NARRATIVE Substantial racial disparities persist in sleep-related infant deaths, which comprise a large proportion of postneonatal deaths; many of the risk factors for these deaths can be modified by changes in parental practice, particularly with regards to sleep and feeding. The overall purpose of the proposed study is to test, through a 4- armed pragmatic randomized controlled trial, an intervention strategy, grounded in health behavior theory, which uses online social networks to disseminate evidence-based information in an attempt to change social norms regarding infant sleep and breastfeeding. We anticipate that impacting the social network and norms will lead to improvements in safe sleep and breastfeeding practices, which in turn may lead to a significant reduction in the incidence of sleep-related deaths, particularly in Black infants.